Computational Ophthalmology and Biomedical Informatics

ABSTRACT
Computational Ophthalmology and Biomedical Informatics Core
The Computational Ophthalmology and Biomedical Informatics Core provides high-performance computing
resources and state-of-the-art custom computer programming to UCSD vision researchers completing
cellular, animal, and human vision research studies. The data analysis requirements of the vision research
community are increasing exponentially as high-resolution retinal imaging datasets become the standard,
genomics research utilizes exome and whole genome sequencing, and the widespread digitization of
healthcare and adoption of electronic health records (EHRs) and other health information technology tools
have expanded the volume of clinical data. The powerful GPU computational condo clusters managed by
the San Diego Supercomputer Center, an Amazon Web Services cloud-based data management pipeline,
custom software tools, and EHR data extraction and analysis services provided by this core facilitate
analysis of these large datasets. The Computational Ophthalmology and Biomedical Informatics core also
supports multiple computational data scientists with expertise in image analysis and signal processing
expertise, big-data analytics, artificial intelligence (AI)/machine learning (ML), relational databases, and
natural language processing to support computational analyses of both basic science and clinical vision
research projects. In addition, essential IT services such as automated off-site backup, fileservers for
secure file-sharing and institutional software licenses (FilemakerPro, Github, FreezerPro) are provided by
the Computational Ophthalmology and Biomedical Informatics Core to the UCSD vision research
community.